Study Design and Data Analytics Facility Core

Project Summary of the Study Design and Data Analytics Facility Core (Data FC)
In the present application, the Center for Environmental Health in Northern Manhattan (CEHNM) will support
three facility cores (FCs)—the Integrative Health Sciences Facility Core (IHSFC), the Exposure Assessment
FC (Exposure FC), and the new Study Design and Data Analytics Facility Core (Data FC). The FCs will
facilitate different aspects of the members’ basic, patient-oriented, population-based, and translational
research. Under IHSFC’s central coordination, the three FCs will form a highly effective pipeline of science to
support members with a wide array of study design, exposure assessment, wet-lab, and data services
throughout all the stages of their investigations. To empower this structure, we propose the new Data FC,
which addresses the growing need for using complex design and advanced computational methods and tools
in environmental health sciences. CEHNM has a long, highly successful record of study design, data
management, and biostatistical support, which are currently offered by the IHSFC. We will transfer these
services in the new and augmented Data FC. The Data FC will offer unique expertise, services, and resources
to assist investigators from study conception through results dissemination.
The Data FC will provide intellectual and computational infrastructure to plan, conduct and analyze studies by
continuing to support existing services, which have a long-standing record of success within the CEHNM,
including: (i) design of observational, clinical and experimental studies; (ii) biostatistical consultations; and (iii)
data management. In this Center renewal, members will find in the Data FC highly expanded capacity,
including: (iv) processing and analysis of a variety of –omics data; (v) training and guidance on handling and
analyzing Geographical Information Systems (GIS) data; and (vi) identifying, accessing, and analyzing the
growing number of large data repositories in the public domain. Throughout these activities, the Data FC will
(vii) offer educational programs on the use of these methods, while (viii) fostering attention to the development
of new methods and tools. The unique combination of new and existing services in the new Data FC will
multiply opportunities and effectiveness in using the rich data that CEHNM members generate—as well as
those already available in-house or in the public domain—to answer groundbreaking questions in
environmental health research. We have a unique opportunity to create this Data FC, because we can build on
our extremely successful record of study design and data support, currently provided by the IHSFC. Over the
first 4 years of the current grant cycle (2013-2016), CEHNM provided study design, data management, and
biostatistical support to 45 pilot grant submissions/projects, 50 grant submissions (12 funded), and 16 pre- and
6 post-doctoral projects. These services directly supported 118 publications.